Bridges to the Baccalaureate Research Training Program at University of Colorado Boulder

PROJECT SUMMARY
This Bridges to the Biosciences Research Training Program represents a new pathway to a baccalaureate
degree in the biomedical sciences for transfer students from Front Range Community College (FRCC
Westminster, FRCC Boulder County) to the University of Colorado Boulder (CU Boulder). The training
mission is to smooth the pathway for underrepresented minority (URM) students to earn their associate
degree from FRCC, transfer to an R1 University (CU Boulder) and complete a baccalaureate degree with a
research emphasis in a life science discipline that prepares them for biomedical research and professions.
The Colorado Front Range, including Denver and Boulder, has a burgeoning biomedical and biotechnology
economy with prolonged and steep growth in STEM employment. Yet fewer than 25% of Colorado students
earn credentials that meet employer objectives. Colorado is the seventh largest Hispanic/Latinx-populated
state in the United States, and the Front Range communities are diversifying rapidly. The need for a prepared
STEM workforce is pressing, and Colorado has an under-tapped population of high-achieving community
college students with diverse backgrounds and great potential to contribute to this workforce demand.
FRCC and CU Boulder are ideal partners due to geographic proximity; high rate of transfer to CU Boulder
STEM majors from across the state; significant percentages of URM, first-generation, and Pell eligible FRCC
students; and high success rate of FRCC students achieving their associate degree. However, there is a
relatively low rate of URM/underserved FRCC students who transfer to CU Boulder. Our institutions have built
strong partnerships for the benefit of student educational advancement and career progression. Systemic
benefits include 1) articulation agreements that provide a clear framework for successful transfer and timely
progression to biomedical science baccalaureate degrees, and 2) guaranteed admission to CU Boulder for all
first-time students who earn an associate degree through the Colorado Community College System (CCCS)
Bridge to Bachelor’s Degree Program. Our objectives are to 1) engage and recruit FRCC students; 2) build
student belonging; 3) build students’ skills, science identity, and self-efficacy; and 4) expand career paths with
greater workforce skills and/or preparation for professional schools. The “human bridges” of our B2B Program
include faculty mentors, advisors, and peer/near-peer role models. This supportive community will engage
early with FRCC students to ensure appropriate course progression and guide a rewarding research focus,
thus nurturing, inspiring, and cultivating confidence in the trainees as they progress toward their baccalaureate
degree. The research of CU Boulder’s best and most engaged life science faculty preceptors is intentionally
broad to resonate with the diverse scientific interests and goals of the B2B trainees. Our overarching goal is to
cultivate Colorado students from URM/underserved backgrounds in the biomedical sciences so that they will
become drivers of scientific inquiries that lead to discoveries important to all communities.

Public health relevance
PROJECT NARRATIVE Colorado’s booming STEM economy requires a prepared biomedical workforce, and numerous career and professional school opportunities in biomedical research and health sciences provide excellent career paths for the diverse Rocky Mountain community. The Bridges to the Biosciences Research Training Program provides a new pathway to a baccalaureate degree in the life sciences for transfer students from Front Range Community College to the University of Colorado Boulder. The training program will promote scientific research opportunities not previously available and will fully engage B2B trainees in scientific education, research, and professional development to increase persistence and retention in biomedical fields.